Harvard School of Dental Medicine Collaborative Clinical Practice-based REsearch Program for DENTal Schools (H-CREDENT)

Project Summary/Abstract
The Harvard School of Dental Medicine Collaborative Clinical Practice-based REsearch Program for
DENTal Schools (H-CREDENT) will embark on an innovative, multidisciplinary practice-based research program
to engage dental students and residents with research and clinical-based faculty to address the challenge of
pain management in dentistry. H-CREDENT is a partnership amongst HSDM, University of New England,
Massachusetts College of Pharmacy & Health Sciences, Meharry University, Charles River Community Health
Center, and Cambridge Health Alliance. The program provides didactic and hands-on clinical research
opportunities to deliver an experiential-learning/training for pre-/postdoctoral students and clinical/research
faculty at these sites. Leveraging the unique diversity in the provider/patient communities brought together by
this collaboration, H-CREDENT strives to prepare the next-generation oral healthcare providers through the
conduct of practice-based clinical research to enhance precision oral healthcare delivery.
H-CREDENT will work towards this goal by accomplishing 2 aims: Aim 1: Establishment of clinical
research skills development program that will train next-generation clinical scholars in practice-based research
networks (PBRNs). Skills development will be advanced via a) coursework in clinical research study design and
PBR, complemented by b) unique pod-based mentorship program for experiential learning. Courses will be
developed by HSDM investigators in partnership with Harvard Catalyst, national PBRN, and a premier network
of private practice clinicians with extensive experience in clinical research. The courses will be taken by H-
CREDENT trainees from all collaborating sites, and each mentoring pod will comprise research-/clinical-focused
faculty and pre-/ postdoctoral trainees from all institutions to promote strong mentorship relationships, both
vertically (e.g., student/faculty) and laterally (e.g., peer-peer) across institutions. Aim 2: A PBRN investigation
to engage dental student and faculty providers to determine risk factors for developing pain following invasive
dental procedures and stratify patients based on demographic, psychosocial, and genetic factors. We will a)
determine risk factors predicting pain after dental procedures and b) how well the dental providers can predict
the patients’ pain experience and if biases influence this prediction, and c) identify patients as low-/ high-risk for
developing post-procedural pain through patient stratification by applying artificial intelligence/ machine learning
methods. This prospective longitudinal study will take place at all sites, where pre-/postdoctoral students will
recruit/enroll, perform dental procedures, and follow up with patients, under the guidance of their clinical mentor.
Differential experiences by H-CREDENT trainees across institutions will be shared via mentoring pods to
integrate and reinforce learnings from the classroom and direct participation in clinical research. Through these
activities, H-CREDENT will foster a culture of scientific inquiry to prepare dental providers with aptitude for
conducting effective practice-based clinical research.

Public health relevance
Project Narrative The Harvard School of Dental Medicine Collaborative Clinical Practice-based REsearch Program for DENTal Schools (H-CREDENT) will engage dental students and residents with research and clinical-based faculty in an integrated, experiential, multidisciplinary dental school practice-based clinical research program. Outcomes of the clinical investigation of disabling pain following dental procedures will allow risk stratification via artificial intelligence/machine learning using patient demographics, clinician management, patient psychosocial determinants, and salivary-based genomic measures. H-CREDENT will advance NIDCR’s national public health research mission in the training of next-generation oral healthcare workforce in the conduct of dental practice- based clinical research.